Admin Core

CORE A: ADMINISTRATIVE CORE: PROJECT SUMMARY/ABSTRACT
The responsibilities of the Administrative Core include monitoring and planning of scientific activities, providing
scientific direction for the P01, ensuring the scientific integrity of all research projects and the integration of all
program components. The Administrative Core is managed by Co- Directors, Drs. Leandro Cerchietti and
Christopher Flowers, who will preside over the scientific quality of the Epigenetic basis and therapeutic
targeting of the unique lymphoma immunological niche P01 and ensure communication, cooperation, and
integration between the different components of the P01 Program. The primary goal of this Core is to assure the
successful oversight and coordination of all projects and cores, through expert guidance in fiscal management,
centralized communication, and general administration for all activities. The Administrative Core will provide
leadership and coordinate the activities of the Executive Committee (which consists of all Project Co-Leaders
and Core Co- Directors), the External Advisory Board member and the Conflict Resolution Committee members.
Specific responsibilities of the Administrative Core include: 1) to oversee all projects and cores, 2) to monitor the
scientific integrity of all research projects, and grant awards, and assure compliance with institutional,
governmental, and National Cancer Institute (NCI) regulations, 3) to monitor and oversee all fiscal and budgetary
issues, 4) to convene all meetings of the P01 Executive Committee, and External Advisory Boards 5) to
communicate with the NCI Program Officer and other NCI staff to prepare all required reports and publications,
6) to notify the NCI Program Officer promptly of important developments that affect the management of the P01
either positively or negatively, 7) to schedule and organize all necessary meetings, including monthly scientific
meetings, lectures, symposia, and attendance at any NCI-sponsored meetings/workshops, 8) to develop and
maintain of effective communication resources for all participants of the P01, 9) to achieve integration with
institutional leadership and other institutional resources, including data management, 10) to ensure all P01
investigators have access to the various institutional cores supported by the WCM Hematologic Malignancy
Program and the MD Anderson Department of Lymphoma and Myeloma and CCSG, and 11) to oversee the
collaboration between the Lymphoma Model Systems (Core 1), Genomics, Epigenomics, Computational Biology
and Biostatistics Core (Core 2), the Multiparameter Imaging and Pathology Core (Core 3), and the P01 Projects.

Public health relevance
CORE A_ADMINISTRATIVE CORE: NARRATIVE The overall goal of the Administrative Core (Core A) is to assure the successful oversight and coordination of all Projects and Cores of the P01 Program, through expert guidance in fiscal management, centralized communication, and general administration for all activities.